Longevity, Equity, and Aging Research Network (L.E.A.R.N.) Consortium Leadership & Administrative Core

PROJECT SUMMARY—LEADERSHIP AND ADMINISTRATIVE CORE
The Longevity, Equity, and Aging Research Network (L.E.A.R.N) Consortium RCMAR brings together a variety
of scientific and medical disciplines to advance knowledge of ethnogeriatric health disparities research by
integrating biological, social and behavioral and cultural aspects using various innovative techniques including
emerging methodologies (biomedical data science, digital health methods, precision medicine techniques and
virtual reality and simulation-based interventions), qualitative research, mixed methods research and
implementation science. The primary focus of the Leadership and Administration (LAC) core is to implement
mechanisms and procedures for (i) timely communication, collaboration, and synergy across the Consortium;
(ii) metric-driven evaluation, including tracking the productivity of our mentored RCMAR Scientists; (iii) financial
management and administrative support; (iv) oversight of the pilot award program; and (v) oversight for human
subjects, data safety, and monitoring procedures in compliance with institutional and federal regulations. The
LAC core will guide, coordinate, and facilitate best practices of the other cores’ activities, ensuring timely and
ongoing cross-core communications to achieve the collective aims. An Executive Committee will be
responsible for the overall scientific and administrative goals and objectives. The LAC core will receive
oversight, input, and support from the External Advisory Committee. By providing an integrated infrastructure
for the logistical and management requirements of the center components, the LAC will increase productivity,
enhance efficiency, and promote unified efforts toward achieving the center’s goals. The Specific Aims of the
Leadership and Administration core are to:
Aim 1: Implement mechanisms and procedures to foster and ensure regular and timely communication,
collaboration, and synergy across the entire L.E.A.R.N. Consortium.
Aim 2: Maintain and continually improve systems and processes for metric-driven evaluation of the L.E.A.R.N.
Consortium to ensure efficiency and productivity of the cores and individual pilot projects, including the tracking
of LE.A.R.N. RCMAR Scientist productivity
Aim 3: Provide financial management and day-to-day administrative support to ensure the efficiency and
productivity of the L.E.A.R.N. Consortium cores and individual pilots.
Aim 4: Oversee the pilot award program in collaboration with the REC Co-Leads and support the Site-PIs at
our Minority-Serving Institution partners, Palo Alto University and San Jose State University, in identifying
Assistant Professor-level applicants from diverse backgrounds to apply to the RCMAR pilot program.
Aim 5: Provide oversight for human subjects, data safety, and monitoring procedures for all pilot projects to
ensure compliance with all institutional and NIH regulations and procedures, particularly the timely
communication with the Institutional Review Board.